Quorum sensing regulation of bacterial development

Project summary
Quorum sensing is a method of cell-cell communication used by bacteria to detect and
respond to changes in population density and control behaviors that benefit the group for
adaption and survival in their environment (e.g., symbiosis and pathogenesis). My research
program is focused on how bacteria use quorum sensing signaling to control expression of
virulence genes. Toward this goal, we study quorum sensing gene regulation in Vibrio species,
both as relevant pathogens and as established quorum sensing model systems. We focus on
the master Vibrio quorum sensing transcription factor LuxR, which is conserved in all Vibrio
species and is the core regulator of hundreds of genes. My research group uses biochemical,
biophysical, molecular biology, and physiological assays to dissect the LuxR mechanisms of
regulation in multiple Vibrio species. These experiments are the foundational components of my
research program.
I am requesting funds to purchase a LI-COR Odyssey M Imaging System. Purchase of
the Odyssey M will expand my lab’s repertoire of assays, increase sensitivity in molecular
analyses, replace older shared equipment, and eliminate costs for radioactive materials and
facilities fees for imaging. We will improve our current biochemical assays with increased
sensitivity via fluorescence-tagged substrates and eliminate the increasing costs of radioactive
materials. In addition, the Odyssey M Imager will eliminate our current use of older, shared
imaging systems for standard molecular biology assays (DNA analysis, protein analysis,
western blots, and plate-based assays). We will further add new technology to my group
because the Odyssey M will enable us to image bacterial infection in situ in Vibrio-infected
tissues using fluorescent antibodies at high resolution. Finally, the included Empiria software
comprises quantification capabilities that are crucial for EMSA and western blot analyses.

Public health relevance
PROJECT NARRATIVE Bacteria communicate using a process called quorum sensing to cooperatively change expression of genes required for pathogenesis. My lab studies the quorum sensing in marine Vibrio bacteria that are human pathogens to deteremine how cell-cell signaling affects gene expression. In this supplement proposal, I am requesting funds to purchase a LI-COR Odyssey M Imaging System to undertake the proposed biochemical and molecular biology assays and cell-based imaging experiments.